The role of complement in chronic neuroinflammation and cognitive decline after closed head brain injury

Traumatic brain injury (TBI) is a major risk factor for early-onset dementia and Alzheimer’s
Disease among Veterans. Cumulative evidence from clinical follow-up of returning Veterans
demonstrate at least 2-4 times higher risk of dementia and cognitive decline compared to matched
non-TBI Veterans. The current interventions for post-TBI dementia are limited, and there are
currently no interventions that have shown to prevent, stop, or reverse cognitive decline in
Veterans who have experienced either mild or severe TBI. Data from animal models of TBI
indicate a role for the neuroinflammatory response in mediating pathological neurodegeneration
after TBI, but characteristics of the neuroinflammatory response, both spatially in the brain and
temporally in relation to cognitive deficits in chronic TBI, has not been explored. In this context,
we have shown that following TBI in mice, there is a robust neuroinflammatory which is observed
at least 6 months after TBI. We have also shown that the complement system is a prominent
trigger of this neuroinflammatory response after TBI. In this project, we propose to investigate the
hypothesis that post-traumatic complement activation and neuroinflammation, that occurs and
persists in the brain following TBI, leads to failure of compensatory mechanisms in primary
cognitive centers of the brain leading to early onset neurodegeneration that is accelerated in an
Alzheimer’s disease mouse model.

Public health relevance
Traumatic Brain Injury (TBI) is a major cause of death and disability among both civilians and military personnel, with about 1.4 million TBI’s occurring each year in the U.S. For military personnel, between 14-20% of surviving casualties had a TBI. Studies proposed investigate chronic effects of closed head brain injury, including cognitive decline and early-onset dementia. This work may lead to a new strategy for improving chronic outcomes after TBI.